Understanding and Addressing the Social Determinants of Health for Families of Children with Sickle Cell Anemia within Pediatric Hematology

PROJECT SUMMARY
Social determinants of health (SDoH)–the conditions in which people are born, grow, work, live, and age–are
key drivers of health and health disparities. Children with medical complexity are particularly at-risk given their
high healthcare need and utilization. Although the American Academy of Pediatrics and payers such as the
Centers for Medicaid and Medicare Services are now recommending medical providers screen for SDoH at
visits, studies have not yet demonstrated the impact of SDoH screening and referral interventions on improving
child health and have fallen short of exploring potential mechanisms by which such interventions could improve
health outcomes. Children with sickle cell anemia (SCA) are an ideal population in which to study the impact of
SDoH interventions given the high prevalence of poverty and unmet material needs among this population and
the disease’s significant morbidity and mortality. This proposal addresses a timely clinically- and policy-relevant
research gap by: (1) implementing a SDoH intervention in two outpatient pediatric hematology clinics and
gathering preliminary data to assess its impact on child health; and (2) characterizing the potential
mechanisms by which addressing SDoH may lead to improved health outcomes. Our team has developed,
tested, and implemented a SDOH intervention (WE CARE) which relies on existing clinical processes to screen
for unmet material needs and refer parents to community services; efficacy data demonstrates its positive
impact on parental receipt of community resources. We now propose conducting a pragmatic pilot cluster RCT
to examine the implementation of WE CARE as standard of care in two of the four hematology clinics. To
preliminarily examine outcomes, we will recruit and follow 100 parents of children with SCA (25 per site) for
one year in order to explore how addressing unmet social needs within the delivery of medical care may
improve healthcare utilization and health outcomes. Given the limitations of applying existing theoretical
frameworks to culturally diverse populations such as those with SCA, we will also employ a mixed methods
approach to characterizing how SDoH influences disease management processes. Our specific aims are to:
(1) Implement WE CARE in two pediatric hematology clinics in order to field test key study logistics and
understand the facilitators and barriers to implementation and accelerate its adoption; (2) Obtain population-
specific empirical estimates of study parameters to plan a large-scale multi-site cluster RCT of WE CARE that
will definitely assess its impact on improving health outcomes for children with SCA; and (3) Qualitatively
assess possible mechanisms linking SDoH interventions to improved health outcomes. This proposal is
innovative because it challenges the current clinical practice and research paradigms for children with SCA. It
has significant implications for child health policy and is a critical step in potentially transforming the delivery of
healthcare for medically complex children.

Public health relevance
PROJECT NARRATIVE Although pediatric professional guidelines are now recommending medical providers screen for social determinants of health (SDoH), there is no evidence to date that SDoH screening improves the health of pediatric patients and studies have fallen short of exploring its impact on the health of children with medical complexity, including children with sickle cell anemia (SCA). The proposed mixed-methods study aims to understand the implementation of a previously tested, efficacious SDOH screening and referral intervention in the outpatient pediatric hematology setting; qualitatively assess possible mechanisms for such interventions on improving child health; and obtain population-specific empirical estimates to plan a large-scale clinical trial. This research aligns with the overarching goal of Healthy People 2020 and NHLBI’s strategic mission of achieving health equity by addressing socioeconomic inequalities that lead to health disparities.